Unraveling the mechanisms behind lymphatic dysfunction in obesity: are weight-loss drugs effective at restoring lymphatic function?

PROJECT SUMMARY/ABSTRACT
Lymphedema is a chronic, debilitating disease affecting >250 million people worldwide with no pharmacological
therapies available. Recently, it has been established that there is a reciprocal relationship between dysfunction
of the lymphatic system and obesity, i.e., obesity causes lymphatic dysfunction and lymphatic dysfunction
exacerbates obesity, creating a vicious cycle. Clinical studies have demonstrated that patients with obesity are
at significantly higher risk of developing lymphedema; and in breast cancer patients, obesity is known to increase
the chances of developing lymphedema following surgical and radiotherapeutic interventions. Therefore, there
is a critical need to identify the molecular mechanisms of lymphatic dysfunction in obesity in order to develop the
first pharmacological therapeutics to treat lymphedema. GLP-1 receptor (GLP-1R) agonists were originally
developed and approved for the treatment of Type 2 Diabetes and recently have been shown to be effective for
reducing bodyweight. However, the effects of GLP-1R drugs on the function of the lymphatic system remain
unexplored. The diet-induced obese ApoE-deficient (DIO-ApoEKO) mouse is a known model to study obesity
and metabolic syndrome, and it also displays various aspects of lymphatic dysfunction; however, the underlying
mechanisms remain unknown. Our preliminary findings using single-cell RNA sequencing on microdissected
lymphatic vessels from non-obese wild type (WT) and non-obese ApoE KO mice revealed significant differentially
expressed genes across many cell types, including lymphatic endothelial cells (LECs), lymphatic muscle cells
(LMCs), and tissue resident macrophages (TRMs). In LECs, several genes in the mitochondrial electron
transport chain were significantly downregulated in ApoE KO mice, suggestive of mitochondrial dysfunction.
LMCs from ApoE KO mice exhibited differentially expressed genes involved in contractile function – both
contractile apparatus and ion channels, suggestive of a change in contractile phenotype. In control mice, Apoe
expression was most abundant in TRMs. TRMs from ApoE KO mice displayed a significantly reduced expression
of M2-like macrophage markers and upregulation of M1-like macrophage markers, suggesting a transition to a
pro-inflammatory polarization. Therefore, to characterize transcriptomic alterations, identify novel molecular
mechanisms of lymphatic dysfunction associated with obesity, and to test the hypothesis that weight-loss driven
by pharmacological targeting of GLP-1R improves lymphatic function in obesity, we propose the following two
independent, but synergistic aims: 1) characterize transcriptomic and functional alterations in lymphatic vessels
from DIO-ApoEKO mice and 2) assess the effects of GLP-1R agonists on the function of collecting lymphatic
vessels and determine the therapeutic potential of GLP-1R weight-loss drugs to improve lymphatic function in
DIO-ApoEKO mice. We anticipate that these experiments will provide novel insights into the molecular
mechanisms that underlie lymphatic dysfunction in diet-induced obesity and hypothesize that GLP-1R agonism
with Semaglutide will improve metabolic changes in DIO-ApoEKO mice and restore lymphatic function.

Public health relevance
PROJECT NARRATIVE Clinical studies have demonstrated that obesity increases the risk of developing lymphedema; however, the molecular mechanisms behind obesity-driven lymphatic dysfunction remain poorly understood, leading to a lack of treatment options. This proposal will 1) identify and characterize transcriptomic and functional alterations in lymphatic vessels from diet-induced obese ApoE KO mice and 2) assess the effects of GLP-1R agonists (i.e. Semaglutide) on the function of lymphatic vessels and determine the therapeutic potential of GLP-1R weight- loss drugs to improve lymphatic function in diet-induced obese ApoE KO mice.